BLR&D Research Career Scientist Application

Neurodegenerative disorders, a group of neurological illnesses, are currently affecting many veterans and
non-veterans throughout the world. Among neurodegenerative disorders, while Alzheimer’s disease (AD)
and Parkinson’s disease (PD) display progressive death of neurons in particular regions of the brain, diseases
like multiple sclerosis (MS) and traumatic brain injury (TBI) exhibit demyelination and axonal
weakness/dysfunction. Our lab primarily focuses on central nervous system (CNS) cell signaling that leads to
neuronal death in PD and AD and demyelination in MS and TBI. All these disorders are characterized by
activation of CNS glial cells (astroglia and microglia), unwarranted production of different proinflammatory
molecules within the CNS, decrease in autophagy, and death of either oligodendroglia (MS and TBI) or
neurons (AD and PD). Therefore, from several angles, we are investigating mechanisms by which glial cells
are activated in the CNS to release different proinflammatory molecules and neurotoxins to cause
neuroinflammation and neurodegeneration, leading to apoptosis and cell death of neurons and
oligodendroglia. We are also involved in identifying intracellular signaling pathways by which lysosomal
biogenesis and autophagy become dysfunctional in the CNS, resulting in protein aggregation or
proteinopathy. Moreover, we will also engage in investigating mechanisms by which glial cells in the CNS
may be redirected to produce neuroprotective molecules and neural stem cells could be driven towards
neurons and myelin-producing cells (oligodendrocytes) within the neurodegenerative CNS. Finally, we are
trying to suppress neurotoxic signaling pathways and/or boost neuroprotective signaling pathways in
different animal models of neurodegenerative diseases by nontoxic drugs/monoclonal antibodies/small
molecules/exercise and translate these interventions from the laboratory to neurology clinics in order to
achieve neuroprotection in patients. Since many veterans are suffering from AD, PD, MS, and TBI, results
from these studies will directly help veterans.
1

Public health relevance
Many US veterans suffer from neurodegenerative disorders such as Alzheimer’s disease (AD), Parkinson’s disease (PD), dementia, multiple sclerosis (MS), and traumatic brain injury (TBI). Therefore, the primary focus of our lab is to delineate signaling pathways in the central nervous system (CNS) that leads to the loss of neurons in AD, PD and dementia, and the death of myelin-producing cells oligodendrocytes leading to demyelination in MS and TBI. All these disorders are characterized by activation of CNS glial cells (astroglia and microglia), production of different proinflammatory molecules, decrease in autophagy in the CNS, and loss of either neurons or oligodendrocytes. Accordingly, we are investigating molecular mechanisms for glial activation, neuroinflammation, autophagy dysregulation, and protein aggregation in order to target pathogenic mechanisms in animal models of different neurodegenerative diseases by nontoxic drugs/monoclonal antibodies/small molecules/exercise for achieving neuroprotection. 1